Senior Research Career Scientist

PROJECT SUMMARY/ABSTRACT
Dr. Ledoux’s current research program aims to reduce both functional and anatomical limb loss by: exploring the
disease processes that lead to aberrant limb function; quantifying the effects of conservative and surgical
treatment options; and developing novel, state-of-the-art technologies for studying the foot. His research focuses
on two Veteran populations: those with musculoskeletal impairment at the foot and ankle, where pain and
limitations in mobility are the key issues (i.e., functional limb loss); and those at risk of lower limb amputation due
to diabetes, where loss of the foot is a major concern (i.e., anatomical limb loss). The overarching goals of his
research include: (1) insight into the pathomechanics of: diabetic foot ulceration, ankle and great toe arthritis,
and severe foot deformities; (2) quantitative comparison of different treatment options for foot pathologies that
can lead to improved limb function or prevention of amputation; and (3) the development of novel research tools.
Dr. Ledoux is working on several projects related to hallux rigidus, or arthritis of the first metatarsophalangeal
joint (MTPJ1). Various designs for MTPJ1 arthroplasties have been proposed, but none have been particularly
successful. Development of new implants aimed at addressing these problems has been limited by insufficient
quantitative data on the MTPJ1 mechanical environment. Similarly, due to previous technological limitations, no
precise 3D data are available on either the kinematics of this disease. CLiMB is engaged in novel research to
identify the kinematic envelope of normal MTPJ1 function required during activities of daily living (RX0032590).
We will build on our initial successes generating novel, evidence-based implant concepts that emphasize strong
initial component fixation to improve MTPJ1 implant technology through computational modeling and robotic gait
simulation of human cadavers (R01AR076475). These better-performing implants will ultimately lead to improved
patient outcomes. It is our working hypothesis that a successful MTPJ1 implant will exhibit both strong initial
component fixation and physiologically normative joint biomechanics. Additionally, Dr. Ledoux is collaborating
with Dr. Sangeorzan on a multisite hallux rigidus study comparing motion sparing procedures (joint replacement
or bone shaping) to arthrodesis (fusion). This study will determine factors associated with treatment success.
Developing improved treatment options requires a better fundamental understanding of diabetic disease
pathomechanics. Despite growing agreement that aberrant pressures and shear stresses are linked to
ulceration, the specific causative mechanism of ulceration remains poorly understood. From a structural
perspective—in which tissues of different material properties and different geometries interact to create a bulk
response—most studies have been 2D and limited in the number of locations considered. Given the complex
structure and functional motion of the foot, it should be investigated in 3D across the entire plantar surface.
However, many techniques that afford volumetric inquiry have other concerns: dissection is disruptive, finite
element models rely on assumptions and simplifications, CT has poor soft tissue resolution, and MRI is
computationally and fiscally expensive. Ultrasound has good soft tissue resolution, but most commercial systems
create planar images or are limited to small, angularly swept volumes. Ultrasound can also be difficult to read
for the naïve user. In order to overcome these barriers, we propose these specific aims: 1) Develop a mechanical
system and the necessary software to generate a 3D scan of the entire plantar soft tissue, using B-mode
ultrasound for structural information and shear wave elastography for tissue properties. 2) Collect plantar soft
tissue scans for 7 diabetic non-neuropathic subjects and 7 non-diabetic subjects. 3) Analyze these scans using
segmentation and strain information calculated with digital volume correlation as well as an interpretable
classification neural network. The successful completion of this NIH funded pilot study (5U24DK115255-04,
subaward 32307-94) will demonstrate the utility of the proposed methods and support a larger grant application.

Public health relevance
PROJECT NARRATIVE Dr. Ledoux’s research portfolio addresses three broad clinical foot problems that are important to Americans in general and Veterans in particular: First, the pathophysiology and treatment of foot (ankle or great toe) arthritis; second, the diagnosis, quantification, and treatment of severe foot deformities; and third, the poor understanding of the effect of diabetes on the plantar soft tissue and the subsequent increased risk of diabetic neuropathic ulceration. Veterans have a significantly higher prevalence of foot problems, including arthritis and flatfoot, than non-Veterans. Similarly, diabetes affects roughly 11% of the general population, but 25% of Veterans. The average age of the Veteran population is much older than the general population and likely contributes to the higher prevalence of these foot pathologies. The sum of Dr. Ledoux’s research aims to explore conservative and surgical treatment options for these three important clinical maladies. He, and his research team, have developed state-of-the-art techniques for addressing these issues.